PATHOGENESIS OF MUCOSAL TRANSMISSION/HIV ACUTE TRANSMISSION

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. To gain a deeper understanding of heterosexual transmission of HIV. Simian immunodeficiency virus (SIV) is an [unreadable] excellent animal model for HIV.[unreadable] [unreadable] The in vivo work has been completed and data analysis continues. These studies will establish mechanisms and dynamics [unreadable] of viral propagation and dissemination and the immune response to the viral challenge. This research used WNPRC [unreadable] Immunogenetics and Virology Services.[unreadable]